Center for Stress and Neural Regulation of Reproductive Aging Health Outcomes

Summary/abstract
Most women experience symptoms and sleep difficulties during perimenopause which can significantly impact
their quality of life. The severity and duration of menopausal symptoms are influenced by psychological,
biological, behavioral, and demographic factors. However, little is known about the associations of climate-
related factors, such as ambient temperature and greenness, with menopausal symptoms and sleep difficulties.
The available evidence on ambient temperature is limited to small studies which suggest that warmer
temperatures are associated with a higher frequency of hot flashes. For greenness, there have been two
longitudinal studies conducted. One found an association between higher exposure to residential surrounding
green space with older age at menopause. The second found that greenness was positively associated with
circulating anti-müllerian hormone levels, a marker of ovarian reserve, predictive of the timing of natural
menopause.
This Diversity Supplement will provide the candidate, Dr. Soria, with the additional experience, expertise, skills,
and data necessary to facilitate her goal of becoming an independent reproductive epidemiologist with expertise
in the exposome and women's health. Dr. Soria will draw upon her background and experience to examine the
associations between climate-related factors and health during the menopausal transition. Specifically, she will
investigate how exposure to ambient temperature and greenness are associated with menopausal symptoms
and sleep duration and quality in women undergoing the menopausal transition. This study will be embedded
within project 2 of the parent grant (U54 AG062322) and use data already collected in the Project Viva cohort.
Dr. Emily Oken and Dr. Jorge Chavarro, the leaders of project 2 of the parent grant, will mentor Dr. Soria. The
candidate will also receive mentorship from Dr. Elizabeth Klerman, a renowned sleep researcher, and Dr. Peter
James, a senior environmental epidemiologist. With the training, skills, and experience she will receive through
the proposed diversity supplement, Dr. Soria intends to seek an academic research position in reproductive
epidemiology.

Public health relevance
Project Narrative Menopausal symptoms can impact women's quality of life during the menopausal transition and in old age. Limited evidence exists on the associations between climate-related factors and menopausal symptoms. The proposed research will shed light on the associations of ambient temperature and greenness with menopausal symptoms and sleep duration and quality in women undergoing the menopausal transition.